ELAV-LIKE PROTEINS IN NEUROBLASTOMA

N-myc amplification and deregulated expression plays a crucial role in determining the clinical behavior of neuroblastoma (NB). Similarly in many NB cell lines, tumorigenicity has been shown to directly correlate with N-myc expression levels. The differential levels of N-myc expression observed in the phenotypically distinct subclones of the NB cell line BBL-W (W-N and W-S), appears to be largely due to cellular disparities in N-myc mRNA turnover. Unlike c-myc and c-fos, little is known about N-myc mRNA metabolism. The turnover of other unstable mRNAs appears to be a consequence of interactions between RNA-binding proteins and 3' untranslated region (3'UTR) AU-rich elements. RNA binding studies performed with W-N and W-S cells demonstrate differential activity of a 40-kDa protein (p40) that binds with high specificity to AU-rich sequences within the N-myc 3'UTR. Immunoprecipitation experiments indicate that p40 is a member of the ELAV-like RNA-binding protein family. It is, therefore, possible that ELAV-like proteins regulate N-myc mRNA turnover, and thereby, modulate the steady-state levels of N-myc expression and NC phenotype. The focus of this study will be to understand the cellular control of N-myc mRNA degradation in NB, and examine the role ELAV-like proteins play in determining NB phenotype. The first specific aim of this proposal is to functionally characterize the N-myc 3'UTR AU-rich sequences that bind p40. Chimeric mRNAs I which N-myc 3' UTR sequences replace the 3'UTR of stable mRNAs will be expressed in NB cells. The decay kinetics ofmRNAs containing mutated N- myc 3'UTR binding sits will be compared to that of non-mutated mRNA, mRNA turnover will also be studied using chimeric transcripts generated by domain interchange between the well characterized c-fos 3'UTR instability elements (which are known to interact with ELAV-like proteins) and the N-myc 3'UTR binding sites. The second specific aim is to study N-myc mRNA decay using in vitro systems in the presence and absence of competitor N-myc RNA fragments. The third specific aim is to characterize the role of ELAV-like proteins in N-myc mRNA turnover and NB phenotype in vivo. ELAV-like protein expression will be altered in NB cells by exogenous gene transfer or by the addition of anti-sense ELAV mRNA or oligomers. N- myc mRNA half-life and tumor cell phenotype and growth potential will be examined in NB cells with enhanced or down- regulated ELAV-like protein expression. In addition, ELAV-like protein expression will be examined in primary NB tumors by Western blot analysis, and the relationship between level of expression and clinical behavior in vivo will be analyzed. A better understanding of N-myc mRNA degradation may lead to novel strategies by which N-myc expression and NB phenotype can be altered. Thus, ultimately, these studies may provide the clues necessary for the development of effective therapy for children with NB tumors that express high levels of N-myc and are clinically aggressive.